Partnerships for Biomedical Research in Arkansas

Development of an integrated informatics and data infrastructure for women’s precision health
Abstract
Arkansas Children’s Research Institute (ACRI), Arkansas Children’s Nutrition Center (ACNC), University of
Arkansas for Medical Sciences (UAMS), and University of Arkansas at Fayetteville (UAF) are building an
innovative Women’s Precision Health Platform for establishing relationships between dietary intake, medical
history, metabolome, microbiome, and women’s health outcomes. The program will leverage past, present and
future research studies of mother and child health at the USDA-ARS funded ACNC and clinical research
programs within ACRI and UAMS, integrating data from studies capturing rich phenotypic data, including
metabolomics, microbiome, genomics and proteomics. This initiative focuses on developing a shared data
infrastructure between UAMS, ACRI and UAF using models established for the IDeA National Resource for
Quantitative Proteomics. The -Infrastructure will support women’s precision nutrition and health research. This
will involve development of a research database, software, and sustainable cloud-based infrastructure to
facilitate machine learning and AI data analytics for metabolomics, genomics, proteomics, microbiome, clinical
biochemical, and patient personal phenotypic data. We will develop a data visualization dashboard to support
monitoring, measuring, analyzing, and visualizing multi-omics data, as well as integrate classic multivariate
statistical methods, time-series data analysis methods, and deep learning-based integration and learning
models. Finally, we will develop workshops and training materials to provide students cross-training in medical
applications database development and informatics research tools. Ultimately this database and research tools
will support fundamental research in the understanding of how critical dietary and lifestyle factors influence
health and disease in women.

Public health relevance
Development of an integrated informatics and data infrastructure for women’s precision health Project Narrative The proposed program will leverage past women’s health cohort and intervention study data to develop an integrated environment for storage, management, integration, and analysis of metabolomics, genomics, proteomics, microbiome, clinical biochemical, and patient personal phenotypic data, for precision health research. The integrative tools will include a research database, software, and cloud-based infrastructure designed to facilitate machine learning and AI data analytics; a dashboard to support monitoring, measuring, analyzing, and visualizing data - providing improved data interfaces and interoperability workflows to support research into the relations between women’s genetics, environment and health.